Doxy4STICare - Doxycycline for Sexually Transmitted Infections; A Comprehensive Assessment of Antimicrobial Resistance and Engagement

Sexually transmitted infections (STIs) represent a significant public health challenge, with increasing
prevalence worldwide. Disproportionately affecting young individuals, gay and bisexual men who have sex with
men (MSM), persons with HIV or on HIV prevention medications, and racial and ethnic minorities, effective
prevention strategies are essential. Doxycycline post-exposure prophylaxis (Doxy-PEP) has been shown to
reduce bacterial STIs; however, knowledge gaps remain, and there are concerns about engagement, effective
use, and the potential antimicrobial resistance consequences. This study proposes a threefold approach to
address these questions. (1) Create a prospective cohort of 500 participants (300 Doxy-PEP users, 200
eligible non-users as a comparator group) to examine baseline and longitudinal factors mapped to the
information-motivation-behavioral skills theoretical framework and identify factors associated with Doxy-PEP
care engagement and effective use. (2) Collect biological samples from the prospective cohort to evaluate the
impact of antimicrobial resistance in persons taking Doxy-PEP using laboratory methods including culture and
resistance testing and metagenomics. (3) Collect biological samples from up to 100 sexual partners of the
cohort to assess the potential for transmission of bacteria between sexual partners using comparative
genomics. By addressing these aims, the study will provide valuable insights into the risks, benefits,
implementation, and impact of Doxy-PEP, informing future strategies to optimize engagement and maximize
STI incidence reduction while minimizing antimicrobial resistance risks.

Public health relevance
Narrative: This study aims to examine the engagement, effective use, the potential for antimicrobial resistance, and potential transmission of bacteria among Doxy-PEP users. A prospective cohort of Doxy-PEP users will be enrolled to investigate factors, mapped to the information-motivation-behavioral skills theoretical model, impacting Doxy-PEP engagement and effective use. Biological samples from Doxy-PEP users, eligible non-users (a comparator cohort), and their sexual partners will be collected to assess trends in antimicrobial resistance of specific pathogens, Doxy-PEPs impact on the presence or absence of resistance genes, and the potential for transmission of pathogenic bacteria between sexual partners.